Delaware Clinical and Translational Research ACCEL Program (BERD Core)

ABSTRACT - BERD
The Biostatistics, Epidemiology and Research Design (BERD) Core of the Delaware ACCEL CTR has matured in the last 9 years into a large, stable yet dynamic core with a repertoire of skills and resources that enables quality clinical and translational (C&T) research. BERD’ s accomplishments result from the close collaboration between ACCEL partner institutions: the University of Delaware, the Nemours Children’ Health system, ChristianaCare Health Services Inc., the Medical University of South Carolina (MUSC) and Delaware State University. BERD assembles a highly-skilled core of skilled biostatisticians, epidemiologists, and bioinformaticians from each institution who have the common goal of advancing translational science and assist C&T investigators. The BERD team from MUSC was instrumental in helping us launch and develop a strong, sustainable BERD over the last nine years, but the DE-based BERD team has matured to a point of independence. Phase 3 BERD will build on this momentum to meet the evolving skills needed for C&T research. With the increasing availability of vast amounts of data, we have the potential to provide deeper insight into the determinants of disease at the individual and population level. To do so, we must develop new methodologies and tools to analyze these data. We will enrich the BERD resources with expertise in Machine Learning (ML), Natural language Processing (NLP), cloud computing, geospatial analysis and novel biostatistics methods to address health for all Delawareans. We propose the following specific aims:1) Expand and enrich consultative services for clinical, translational and population health sciences. BERD will leverage the expertise in ML, NLP, cloud computing, and geospatial analysis that already exists in some ACCEL-CTR institutions and will make this expertise available to all investigators; 2) Develop innovative methods in biostatistics and data sciences including reducing selection biases, enhancing the power of studies, and developing design and analysis plans for studies of unique populations or with very small numbers of subjects; 3) Promote virtual self-paced synchronous and asynchronous learning opportunities. We will continue to offer TechTalks and Innovative Discoveries Series lectures and will vet on-line material for posting on our Education hub; 4) Expand the biomedical informatics research infrastructure by leveraging expertise and skills acquired in the last nine years to establish an integrated network of resources focused on addressing critical healthcare needs in Delaware. The BERD specific aims build upon the overall aims of the ACCEL CTR phase 3. By expanding BERD expertise to better meet the needs of investigators, we will improve the scientific infrastructure and culture. We will develop innovative methodologies to foster projects aiming at improving health for all Delawareans. Access to the cloud will allow teams of clinicians and scientists to develop projects that have high clinical impact. Access to asynchronous learning will help clinician researchers to sharpen their skills in biostatistics/epidemiology.

Public health relevance
Project Narrative While Delaware has high quality healthcare compared to other states, it still lags behind other states in a number of areas, including drug-related deaths, obesity, high preventable hospitalization rates, multiple chronic conditions and cancer. As such, the overarching goal for the continuation of the ACCEL CTR Program is to create a unified Delaware Clinical and Translational Research Community (inclusive of investigators and community members) that breaks down existing barriers, capitalizes on the unique strengths of its partners to establish infrastructure and accelerates the creation of solutions that improve the health of all Delawareans and all Americans.